Administrative Core

Project Summary/ Abstract
The Center for Addiction and Disease Risk Exacerbation (CADRE) Administrative Core will provide the scientific leadership and administrative support necessary to ensure the success of this Phase II COBRE. Thus far, we have made excellent progress in establishing an integrated multidisciplinary center that fully leverages the resources of Brown University, its affiliated hospitals, and the broader community, to address the link between substance use (SU) and chronic disease (CD). We have successfully transitioned four of six Project Leads to R01 independence. Our four Admin Core specific aims are: Specific Aim 1 – To further solidify a team and organizational structure that provides leadership and administrative support for scientific excellence and facilitating the goals of the CADRE. Specific Aim 2 – To provide state-of-the-art mentoring support and initiatives for the CADRE PLs and PPLs to facilitate their success in achieving independent grant funding. Specific Aim 3 - To increase the disciplinary range of investigators addressing SU in chronic disease, we will administer a pilot project program and recruit postdoctoral fellows with backgrounds spanning the social sciences, data sciences, medicine and nursing. Specific Aim 4 – To conduct ongoing evaluation of the overall CADRE, including its Cores, Research Projects, Pilot Research Projects, on scientific and career development objectives, so that CADRE is continuously evolving and improving. In Phase II, we will have a fully engaged five-member Advisory Committee with both disciplinary depth and breadth, and the support of 28 senior faculty members at Brown and its affiliated hospitals who will serve as CADRE affiliated scientists. Our choice of Principal Investigator and Deputy Director continues to be one of our strengths, as both have extensive experience in research, training, and mentoring that strongly complement one another. Dr. Monti (PI) is a clinical psychologist who has been at Brown for decades. He directed the Center for Alcohol and Addiction Studies (CAAS) from 2000 to 2022 and was director of the NIAAA T32 for the past 32 years. Dr. Ahluwalia (Deputy Director and Director, Admin Core), an NIH funded physician scientist, has been at Brown since 2017. While at Univ. of Minnesota, he was PI of a NIMHD P60 Center of Excellence and associate director of the CTSA. Both have served on NIH National Advisory Councils, Monti for NIAAA and Ahluwalia for NIMHD. With this significant NIH and institutional investment, we will be able to extend our current work to ensure it propels the careers of promising early career faculty, expands the biomedical workforce, and addresses health outcomes across populations at risk for SU and chronic disease.